Archaea as a microbial model for developmental mechanoplasticity

PROJECT SUMMARY
Cells with identical genomes can follow different developmental paths depending on their mechanical
interactions with the environment. Archaea impact human health by playing critical roles in environmental cycles
and animal microbiomes. Yet little is known about their cell biology. In contrast to most microbes, archaea are
as plastic as mammalian cells, have low turgor pressure, and lack a rigid cell wall. Hence, to advance the
mechanistic understanding of how microbiome complexity influences human physiology, it is crucial to
understand how archaea respond to mechanical stresses under intermittent crowding changes that mimic the
human microbiome. Under this light, our group studies the fundamental principles of how archaeal cells convert
mechanical signals into biological outcomes in the face of shear, confinement, osmoshock, and crowding. This
proposal furthers our vision by using (1) a top-down approach in which archaeal mechanoresponses are
quantitatively and systematically described across spatial-temporal scales from populations to cells and cellular
processes; (2) a bottom-up approach to uncover the specific activity-dependent molecules and molecular
functions orchestrating cellular and populational responses. To address the first thrust, multi-layer microfluidic
devices will be integrated with imaging-based analysis of cellular organization, behavior, biomechanics, sub-
cellular dynamics, and gene expression profiles under different shear, compression, and crowding levels.
Preliminary data suggests that shear and confinement trigger dramatic but distinct developmental programs in
the haloarchaeon model Haloferax volcanii. Closing the gap toward the venture, the second direction will provide
mechanistic insights into how different mechanoresponsive factors contribute to the described phenomena
above. We will focus on mechanosensor candidates identified by us and other groups, including cytoskeletal
polymers (volactin, halofilins, CetZs), mechanochannels, and immunoglobulin glycoproteins. In parallel, we will
also leverage the power of protein pulldowns and in vitro reconstitution, combined with the whole-genome
CRISPRi library recently built in our group, to expand the interactome and identify new molecular and biophysical
pathways underlying mechanosensation. Our past studies and preliminary results demonstrate i) technical skills
in mastering microfluidics and advanced archaeal live-cell imaging to probe molecular and biophysical
mechanisms, ii) cultivation and reverse genetics of dozens of archaeal species, and iii) proof of concept that
some of our dashing ideas will yield valuable insights in laboratory model systems. Our research program
envisions a better understanding of how microbes adapt in reconstituted environments akin to human
physiological conditions, supporting future mechanistic in vitro and in vivo multi-species microbiome studies.

Public health relevance
PROJECT NARRATIVE Archaea are microbes necessary for human gut health, yet little is known about how they respond under human physiological conditions. This project aims to study how archaeal cells sense mechanical forces, such as the ones in body fluids (shear flow) and compression (against animal tissue and by other microbes), and translate them into biochemical responses. Understanding responses to mechanical stresses will help to connect archaea to known disease-causing microbes.